Novel approaches for assessing the relationship between stress, cognition, and alcohol biomarkers in real-time

PROJECT SUMMARY / ABSTRACT
Alcohol use disorder (AUD) is a heterogeneous and relapsing illness. Poor treatment outcomes for AUD
highlight the need to investigate the mechanisms that increase risk for harmful alcohol use. Two factors that have
been independently associated with harmful alcohol use are stress and executive function. However, the use of
objective biomarkers and longitudinal assessments to assess these variables in the real-world settings is limited.
Further, these variables are predominantly investigated in treatment-seeking individuals, potentially limiting the
generalizability of findings to the larger AUD population. Thus, this K01 will investigate the relationship
between objective measures of stress, executive function, and alcohol use in laboratory and real-world
settings in non-treatment seeking individuals with AUD. Aim 1 will characterize the relationships between
laboratory and real-world stress biomarker measures. Aim 2 will examine the associations between stress and
alcohol biomarkers in real-world settings. Aim 3 will determine if the relationship between stress and alcohol
biomarkers is moderated by executive function in real-world settings. Findings from this study have the potential
to improve assessment accuracy and the field’s understanding of mechanisms underlying the addiction cycle,
as well as inform interventions for AUD.
Situated in a supportive environment within the Department of Community and Behavioral Health at
Washington State Univeristy Health Sciences Spokane, I have access to well-funded mentors, space,
equipment, and protected time to conduct my research. To gain the expertise needed to complete the proposed
aims, a comprehensive mentoring training plan has been developed for me to: 1) gain expertise in the
identification and assessment of mechanisms that drive drinking behavior in order to inform interventions; 2) gain
expertise in collecting, managing, and analyzing intensive longitudinal data (i.e., ecological momentary
assessment); and 3) acquire proficiency in utilizing biomarkers and innovative technologies to assess stress,
cognitive function, and alcohol use in laboratory and real-world settings. The proposed training plan integrates
mentorship from experts in basic and applied human research (McPherson), mechanisms of behavioral change
and the ecological validity of remote neuropsychosocial assessments (Chaytor), intensive longitudinal
assessments and ecological momentary assessment methods (Cleveland), mobile health technologies
(Ghasemzadeh), stress and the addiction cycle (Sinha), and biomarker analyses (Hill-Kapturczak). This
Mentored Research Scientist Development Award will provide vital protected time, resources, and mentorship
that will build on my previous training and support my long-term career goal of becoming a successful
independent investigator with a research program that utilizes basic and applied research methods in real-world
settings to investigate mechanisms that underlie addiction and inform interventions for substance use disorders.

Public health relevance
NARRATIVE While stress and executive function have independently been associated with harmful alcohol use, these variables have predominately been investigated in controlled laboratory settings and treatment seeking individuals with alcohol use disorder, thereby potentially limiting the generalizability of findings. Using novel technologies and intensive longitudinal assessments, the proposed study will investigate the relationship between objective measures of stress, executive function, and alcohol use in laboratory and real-world settings in non-treatment seeking individuals with alcohol use disorder. Findings from this study have the potential to improve the field’s understanding of mechanisms underlying the addiction cycle and inform interventions for AUD.